Biophysical Basis of Muscle Functional MRI

DESCRIPTION (provided by applicant): This is an application for competitive renewal of an R01 award entitled Biophysical Basis of Muscle Functional MRI. In the previous cycle, we developed an improved understanding of the physiological basis of MRI contrast in skeletal muscle, especially blood oxygenation-level dependent (BOLD) effects, and developed diffusion-tensor MRI (DT-MRI) fiber tracking methods for quantitative characterization of muscle structure. In the proposed studies, we will advance these techniques further and then bring them to bear on Becker and Duchenne muscular dystrophy. These are severe neuromuscular disorders characterized by a missing or dysfunctional form of the cytoskeletal protein dystrophin. The resulting phenotype includes inflammation, muscle fiber necrosis with fat replacement and fibrosis, perfusion deficits, and reduced maximum stress- generating capability. In this application, we propose the novel hypothesis that fat replacement alters the normal muscle fiber architecture, impairing the normal relationships among muscle fiber geometry, stress and strain development, and perfusion. Therefore, our overall objective for this application is to advance MRI techniques for characterizing skeletal muscle structure and function, in order to elucidate novel aspects of the linkage between the skeletal muscle structural abnormalities and impaired mechanical and physiological performance in the dystrophinopathies. Aim 1 is to quantify muscle architecture patterns in fat-infiltrated muscle and the normal relationship between architecture and strain development during isometric contractions. These studies will build on the advancements made in DT-MRI fiber tracking in the previous grant cycle and provide new understanding of normal muscle structure-function relationships. Aim 2 is to develop and implement improved MRI methods for quantifying muscle blood flow, volume, and oxygenation changes during exercise and determine the effect of fiber curvature on perfusion. This aim will capitalize on the improved understanding of BOLD contrast in skeletal muscle that we built during the last funding period and integrate these methods with perfusion and blood volume measurements for a comprehensive characterization of oxygen delivery and use by exercising muscle. Aim 3 is to quantify the relationships among skeletal muscle architecture, muscle strain development, blood flow, and oxidative metabolism in healthy and dystrophic muscle. These studies will build on the work accomplished during the previous funding period, advance new tools for characterizing skeletal muscle in health and disease, and provide new insight into the pathological processes accompanying the loss of functional dystrophin in skeletal muscle.

Public health relevance
Narrative Becker muscular dystrophy is a severe neuromuscular disorder characterized by muscle wasting. However, the functional deficits associated with this wasting are not completely understood. In this application, we will develop new magnetic resonance imaging techniques for studying these deficits.